Non-coding genetic risk variants modulating Tregs in arthritis

Project Summary
This K01 award provides Dr. Taehyeung Kim with the advanced research training, protected time, and
mentoring needed to become an independent investigator specialized in functional genomics and committed to
understanding the regulatory role of genetic variants conferring disease risk through Tregs.
Candidate: The PI is an Instructor at Harvard Medical School in the laboratory of Dr. Peter Nigrovic in the
Division of Immunology at the Boston Children’s Hospital. His previous training has provided him with
extensive knowledge in the genetics of human diseases, as well as technical expertise in gene and genome
editing, molecular biology, biochemistry, and manipulation of human primary immune cells.
Research: Epigenetic analysis of RA GWAS variants implicates Tregs in disease risk, but how these variants
affect Tregs remains largely unexplored. The PI found that the non-coding variant rs3087243 affects the
immune control gene CTLA4, likely mediated by the transcription factor EGR2. Remarkably, healthy individuals
carrying this risk allele have lower CTLA4 expression and fewer Tregs, potentially due to CTLA4 signaling
inhibiting mTORC1. Further, we experimentally identified 197 SNPs as potential functional variants linked to
RA/JIA risk via Tregs, based on allele-specific binding to Treg nuclear proteins. In Aim 1, we will investigate
how rs3087243 controls Treg abundance. In Aim 2, we will uncover novel SNP-Gene-Phenotype pathways
along with their regulatory mechanisms in Treg immunity, opening up the possibility of therapeutic targeting.
Mentoring/Training: The PI's goal is to become an independent investigator and a tenured faculty member at
a premier academic institution. The proposed research and training plan is crafted to position the PI to obtain
independent R01 funding and to become an internationally recognized authority in the field of functional
genomics of immune cells in autoimmune diseases. By leveraging a network of experts in his field of study, he
aims to gain a deep understanding of how the human genome orchestrates cell phenotypes and the
implications of dysregulation in autoimmune conditions. His research training will encompass CRISPR-based
genome editing, computational biology to analyze immune cell functions through single-cell RNA-seq, and
advanced techniques in immune cell phenotyping and manipulation. Additionally, he will acquire essential
laboratory leadership skills to smooth the transition to his independent laboratory. This endeavor will unfold in
an exceptional institutional setting, under the guidance of Dr. Nigrovic, an authority in immunology of
autoimmune arthritis, Dr. Maria Gutierrez-Arcelus, an expert in functional genomics and systems biology, and
an Advisory Committee comprised of Drs. Talal Chatila, a Treg biology specialist; Dr. Nir Hacohen, a luminary
in molecular genomics; and Dr. Matthew Weirauch, an expert in transcription factor biology.

Public health relevance
Project narrative GWAS have connected over 100 non-coding variants to the risk of rheumatoid arthritis (RA) and juvenile idiopathic arthritis (JIA), but for the large majority of these variants their function remains unknown. The PI has identified a risk variant for RA that regulates expression of CTLA4 and has also found additional risk variants for RA and JIA that are suspected to be functional via their activity in Treg cells. The project aims to understand how the CTLA4-regulating variant affects Treg abundance and function, and to employ non-coding variants to identify new pathways controlling Tregs in a manner directly relevant for arthritis risk.